Visual feature competition between central and peripheral retinal pathways’

Project Summary/Abstract
Eye fixation enables us to see details of objects that require current attention using a specialized region in
the retina called high-acuity area (or the fovea in humans). During eye fixation, visual inputs detected in the
peripheral retina that may induce disruptive reflexive eye movements, such as optokinetic reflex (OKR), are
suppressed. Eye movement and fixation are often disrupted in degenerative diseases in the early visual
system (e.g. partial macular degeneration) as well as in high-order neural disorders. However, how the visual
signals that evoke these two eye movements interact at the beginning of the vision, in the eye, is not well
understood. In the eye, photoreceptors capture pixel representation of the visual scene. These signals are
processed and transformed into visual feature representation, such as object motion, which triggers eye
fixation, and background movement, which triggers OKR, in the retina before being sent to the brain. We
hypothesize that these two visual feature signals interact with each other in the retina. To investigate this, we
will use larval zebrafish as a model system. As larval zebrafish are transparent and easy to generate
transgenic animals, this system uniquely allows us to optically record and optogenetically control neural
activity throughout the visual system in behaving animals. This research will be the first to carry out such
analysis in the retina. We will first behaviorally assess whether larval zebrafish can perform eye fixation in
the presence of background movements. Next, using two-photon imaging of neural activity, we will identify
the neural pathways that process eye fixation and OKR-evoking signals in the retina and retinal-recipient
areas. Finally, by simultaneously recording behavior and neural activity in the eye and the brain, we will reveal
how and where along these pathways, eye fixation and OKR-evoking signals interact with each other for
selecting behaviors.
Neural mechanisms underlying individual feature extraction in the retina have been extensively studied.
Furthermore, these studies revealed that some of the feature signals are directly linked to behavior, such as
OKR and eye fixation. However, in nature, we face visual scenes with multiple features that may compete
with each other for behaviors, and the extent to which the neural basis of this computation is based in the
early visual system, including the retina and retinal recipient areas of the brain, is less understood. By
providing new fundamental knowledge about the circuitry and logic underlying the competition between
central and peripheral vision, this project has broad implications for both normal and pathological vision.

Public health relevance
Project Narrative Eye fixation enables us to see details of objects using a specialized central area in the retina and is critical for carrying out daily tasks, such as reading and driving vehicles. Using transparent larval zebrafish to investigate neural activity in the retina and the brain during eye fixation tasks, this project aims to uncover the role of the early visual system in controlling eye fixation in naturalistic settings, where background scenes may trigger disruptive eye movements. As eye fixation is often disrupted in diseases affecting the early visual system and high cognitive functions, the findings from this research will provide fundamental knowledge about how eye fixation is controlled in challenging visual environments.